The Physiology of the Weight Reduced State Data Coordinating Center

Supplemental funding is requested for the Data Coordinating Center (DCC) for the Physiology
Of the Weight Reduced State (POWERS) consortium. Though the Request for Application
indicated that there would be support for “up to two Clinical Centers”, one of the successful
applicants included 3 institutions. With the DCC budgeting the single IRB (sIRB) costs for two
Clinical Centers, additional funding will be needed due to additional costs for IRB costs for the 4
institutions comprising the two Clinical Centers. Additionally, the funding for the study website
did not include costs related to using the website as a recruitment tool or for data collection.
Finally, the more extensive data collection being proposed once the protocol began to be
developed, including data streams from several devices, was not including in our original
application.

Public health relevance
The POWERS consortium is currently developing a protocol that includes substantially more data collection, from more data streams, than was envisioned in our proposal. The website will have more functionality. This results in the need for additional effort provided by investigators and other DCC personnel. With one of the Clinical Centers including multiple institutions, the costs for the single IRB are higher than anticipated.